Longitudinal trajectories in treated and untreated schizophrenia

Studies of the untreated course of non-affective psychosis have been largely limited to urban samples with
short duration of untreated psychosis (DUP) (less than 5 years). We propose to take advantage of a unique,
time-limited opportunity to study the extended untreated course of psychosis among individuals with psychosis
(IWP) with very long DUP (>30 yrs), in predominantly rural areas of China. Our first goal is to develop
knowledge about the course of untreated ongoing psychosis and associated neurobiology over a span of
decades. Our second goal is to expand knowledge about initiating treatment (e.g. antipsychotic medications) in
IWP who remain untreated into late adulthood. This R01 proposes a 3-year follow-up of 400 untreated IWP,
400 treated IWP, and 400 healthy controls (HCs) from mainly rural areas of Guangxi Province and Hunan
Province (matched on key variables). Our primary focus is on cognitive performance, but we will also compare
the 3 groups on other symptomatic and functional domains. Moreover, comparisons of prolonged untreated
IWP who accept treatment (i.e., the ‘newly-treated’) versus refuse treatment (i.e., the ‘ongoing untreated’) will
provide crucial information about the effects of initiating antipsychotic treatment in IWP with extended DUP.
Our specific aims include: Aim 1) compare change in cognitive performance from baseline to 3-year follow-up
in 3 groups: ongoing untreated IWP, matched treated IWP, and matched HCs. 1a) we hypothesize in the
primary analysis that decline in cognitive performance over 3-year follow-up, measured by the MATRICS
Consensus Cognitive Battery (MCCB), will be greatest in the ongoing untreated group, intermediate in the
matched treated group, and least in HC. 1b) a secondary analysis will similarly compare changes in specific
cognitive domains and those who show progressive cognitive declines between the 3 groups, in the same
order hypothesized in 1a). Aim 2) conduct secondary analyses to compare change in measures of
psychopathology, social and vocational functioning, medical co-morbidity, and social burden from baseline to
3- year follow-up among the same 3 groups specified in Aim 1. Aim 3) conduct secondary analyses comparing
the ongoing untreated and newly treated groups with respect to: 3a) change in cognitive performance; 3b)
change in psychopathology, functioning, medical co-morbidity, and social burden. In Aims 3a) + 3b), we
identify characteristics of newly treated IWP who remain nonresponsive to treatment. 3c) identify patient-,
family-, and other stakeholder-level factors associated with medication uptake via the 686 Program. Aim 4) via
capacity-building, we identify a cohort of new clinical researchers and provide training via this large-scale study
in guiding them towards sustainable research careers. Finally, in exploratory analyses, we will compare “brain
age gap” (i.e., an imaging measure of brain age minus chronological age) over the 3-year period in a subset of
individuals from each group. We propose to illuminate the course of cognition in a large sample of prolonged,
untreated psychosis, thus advancing understanding of psychosis in China, other LMICs, and worldwide.

Public health relevance
A global mental health priority is to identify and treat individuals with non-affective psychosis in low and middle income countries. This project seeks to: (1) develop knowledge about the course of chronic untreated psychosis and to provide a rare source of insight into the underlying nature of the illness that may illuminate key pathophysiological pathways of psychosis worldwide; and (2) expand knowledge about initiating medication treatment among individuals with psychosis who remain untreated into late adulthood. This will be especially relevant to low- and middle-income countries where treatment is being scaled up to reach individuals with psychosis in rural communities where duration of untreated psychosis can be very long.